The 1st International SynBYSS Conference

SynBYSS_Project Summary
The SynBio Young Speaker Series (SynBYSS) is a virtual weekly seminar started in 2021, that
will begin having in-person meetings. Synthetic biology is an interdisciplinary field with
applications in biomedicine, biosafety, biotechnology, and pharma. Yet, there are now fewer
synthetic biology conferences than in the past, and none of the conferences focuses on early-
career researchers. Moreover, the youngest members are a diverse and international group
without obvious representation. At most conferences few of them have opportunities to express
their ideas, network, or collaborate. With this in mind, the conference will focus on what the
future holds for synthetic biology. A central objective of the conference is to bring the community
together for more interactive, inclusive, and collaborative discussions. Talks will focus on young
researchers paired with keynote speakers, similar to the online series. There will be discussion
panels and networking events to actively promote collaborations between researchers at
different career stages, thus facilitating the generation of an effective combination of new ideas
and expertise. Funding from NIH will be used to offset registration fees and travel costs for a
cohort of diverse early-career NIBIB SynBYSS fellows. This R13 aligns with NIBIBs ongoing
NOSI for synthetic biology for biomedical applications.

Public health relevance
SynBYSS_Project Narrative The SynBio Young Speaker Series (SynBYSS) is a virtual weekly seminar series with an explicit goal of highlighting the contributions of early-career researchers in synthetic biology and biomedicine. This R13 proposal will provide scholarships to underrepresented and early-career scientists as NIBIB SynBYSS Fellows to attend the in-person event of the series.